RFA-GH-21-006, SICA Study: Seroepidemiological Insight into COVID-19 transmission in Africa

PROJECT SUMMARY
The COVID-19 pandemic has resulted in vastly different health outcomes for populations in Sub-Saharan Africa
as compared to other countries with comparatively higher case numbers and deaths. The comparatively low
numbers of cases and deaths reported in the Democratic Republic of Congo (DRC) and Nigeria, as well as
throughout sub-Saharan Africa, are likely reflective of poor healthcare infrastructure and limited testing capacity.
It is also unclear how the level of transmission of SARS-CoV-2 in urban vs. rural settings may influence COVID-
19 severity and the subsequent identification of cases by testing sites in both countries. Our overarching
hypothesis is that prior exposure to related coronaviruses and other pathogens, which partition differentially in
urban vs. rural communities, have resulted in significant cross-protective immunity or innate immune priming in
the population, which leads to a reduced COVID-19 burden in these countries. We will leverage ongoing
longitudinal cohort studies in urban and rural sites in the DRC and Nigeria, to support the characterization of: (i)
the incidence of and risk factors for SARS-CoV-2 infection and COVID-19 severity, (ii) the current distribution
and severity of respiratory/non-respiratory viral and non-viral pathogens as a cause of non-COVID-19 acute
febrile illness, and (iii) role that exposure to syndemic pathogens have on COVID-19 severity. To this end, we
propose to describe the incidence and prevalence of SARS-CoV-2 using seroepidemiology and describe factors
associated with incidence and recovery (AIM1) and the epidemiology of respiratory and non-respiratory viral or
parasitic pathogens viz. acute febrile illness (AFI) during the COVID-19 pandemic (AIM2). Our long-standing
relationships through community engagement activities, and direct ties to the Public Health ministries as well as
the Africa Centres for Disease Control allow us to obtain and convey accurate data at local resolution. We
envision that this multinational surveillance project will provide much needed insight into the epidemiology of
SARS-CoV-2 infection and COVID-19 disease in the DRC and Nigeria, elucidating differences in the incidence
and disease outcomes across a range of urban vs. rural settings, which in turn can inform public health policy
and control measures at country and regional levels.

Public health relevance
PROJECT NARRATIVE The COVID-19 pandemic has resulted in vastly different health outcomes for populations in Sub-Saharan Africa as compared to other countries with comparatively higher case numbers and deaths. We propose to leverage ongoing longitudinal cohort studies in urban and rural sites in the Democratic Republic of Congo (DRC) and Nigeria, to support the characterization of: (i) the incidence of and risk factors for SARS-CoV-2 infection and COVID-19 severity, (ii) the current distribution and severity of respiratory/non-respiratory viral and non-viral pathogens as a cause of non-COVID-19 acute febrile illness, and (iii) role that exposure to syndemic pathogens have on COVID-19 severity. This project will provide critical insight into the epidemiology of SARS-CoV-2 infection and COVID-19 disease in the DRC and Nigeria, elucidating differences in the incidence and disease outcomes across a range of urban vs. rural settings, which in turn can inform public health policy and strategy.